1 25 &2 5MG OF LEVORMELOXIFENE VS PLACEBO FOR TREAT OF POSTMENOP OST

This study will examine the safety and effectiveness of Levormeloxifene in the reduction of the incidence of vertebral (and possibly other) fractures in post-menopausal women who have osteoporosis and are at high risk of such fractures.